Towards an iNPC-proSAAS therapy for Parkinson's disease

SUMMARY
Cellular chaperones are promising targets for therapeutic intervention in neurodegenerative disease due to
their ability to limit misfolding and promote degradation of pathological proteins. ProSAAS is among the few
brain-specific chaperones that are actively secreted and therefore capable of interacting with toxic proteins in
both the extra- and intra-cellular environments, making it particularly attractive as a therapeutic candidate.
Moreover, ProSAAS has been identified as a potential biomarker for Parkinson’s disease (PD) and is
colocalized with Lewy bodies in post-mortem PD tissue. ProSAAS blocks alpha-synuclein (α-Syn) fibrillation
and α-Syn toxicity to rat dopamine (DA) neurons in primary culture and its lentivirus-mediated overexpression
in rat substantia nigra (SN) protects DA neurons from AAV- α-Syn toxicity in vivo, even when administered
several weeks after the onset of motor deficits, portending therapeutic efficacy in post-symptomatic PD.
Overexpression within DA neurons themselves may not be required for neuroprotective benefit since delivery
of lentivirus-proSAAS to the striatum is as effective as nigral delivery in protecting against nigral AAV- α-Syn-
induced motor deficits. This is significant because it suggests that proSAAS delivery to the DA terminals in the
more accessible caudate-putamen is a viable therapeutic strategy for PD. It is currently unknown if the
protection afforded at the DA terminal level requires proSAAS release from neuron terminals making synaptic
contact with DA terminals or whether a more diffuse delivery of proSAAS would be effective. The translational
significance of this question lies in the several benefits offered by a genetically modified astrocytic cell
transplantation approach to proSAAS delivery over direct viral inoculation, including: 1) avoidance of insertional
mutagenesis; 2) ability to incorporate larger, controlled expression constructs; 3) benefits provided by
supportive astrocytes 4) enhanced tissue penetration afforded by cellular ramifications. We have therefore
produced human induced pluripotent stem cell (iPSC)-derived neuroprogenitor cells (iNPCs) expressing
proSAAS and will test their efficacy in both cell culture and in vivo PD models. Rat primary DA neurons will be
co-cultured with iNPC-proSAAS or control iNPCs and exposed to human α-Syn-expressing AAV or α-Syn
preformed fibrils, with DA neuron survival and p129-aSyn staining as the output measures (Aim 1a). In parallel,
iNPC-proSAAS will be co-cultured with human iPSC-derived DA neurons from patients with young-onset PD
(YOPD) to test their effectiveness in attenuating previously demonstrated elevated endogenous soluble α-Syn
protein levels (Aim 1b). The effectiveness of iNPC-proSAAS striatal transplantation in providing
neuroprotection will be tested using in rat unilateral nigral AAV-haSyn and aSyn preformed fibril PD models.
Positive results would confirm that proSAAS offers protection to DA neurons in a non-cell-autonomous fashion
and support progression to iNPC-proSAAS IND-enabling studies.

Public health relevance
NARRATIVE The project aims to evaluate the potential of a novel genetically modified human induced pluripotent stem cell transplantation approach, targeting the secreted protein chaperone – proSAAS, for reversing neurodegeneration in an animal model of Parkinson’s disease.